Molecular Genetic Analysis of Mycobacterium Tuberculosis

PROJECT SUMMARY / ABSTRACT
Although Tuberculosis is a disease, for which we have a vaccine and sterilizing chemotherapy, WHO reported
8 million new cases and 1.6 million deaths from TB in 2016. This is surprising since the causative agent;
Mycobacterium tuberculosis was isolated in 1882 by Robert Koch. When active TB develops, a cure normally
requires six months of treatment, known as ‘short-course’ chemotherapy. However, for individuals infected with
multidrug-resistant M. tuberculosis, the minimal duration of treatment is one to two years. We hypothesize the
requirement for long treatment periods are the result of persistence --- the capacity of M. tuberculosis to resist
sterilization in a mammal. Clearly, knowledge of persistence could lead to new strategies to control TB globally.
However, the acquisition of basic M. tuberculosis knowledge was historically limited by the inability to transfer
genes into this bacterium. This proposal was originally funded following our 1987 publication demonstrating
that it was possible to transfer genes into M. tuberculosis using a mycobacteriophage cosmid vector (shuttle
phasmid). Shuttle phasmids allowed for the development of genetic tools, including the first plasmid
transformation system, efficient transposon mutagenesis, specialized transduction, and luciferase reporter
mycobacteriophages for rapidly assessing drug susceptibilities. This resubmission for competitive renewal
builds on our expertise with mycobacteriophage-based tools and our extensive preliminary data to study
persistence. Gene transfer elucidated the mechanisms of action and resistance to the front-line TB drug
isoniazid (INH), which led to our development of an in vitro model to observe INH-tolerant cells --- a
subpopulation of M. tuberculosis cells (0.1 to 1 %) that survive INH exposure without resistance mutations.
Importantly, we discovered that cysteine and vitamin C prevent INH tolerance, resulting in culture sterilization,
and that INH tolerance is mediated by a stress-induced phenotype that correlates with slower cell division. We
have further determined that inactivation of the non-essential sigma factor SigE leads to the loss of INH
tolerance and that starvation for methionine and arginine also lead to sterilization of M. tuberculosis cultures.
Moreover, our RNAseq analysis identified an island of M. tuberculosis genes that is activated by sterilizing
conditions. This proposal plans to elucidate mechanisms of INH tolerance in vitro and in vivo using specialized
transduction and libraries of barcoded deletion mutants. In addition, we will develop novel dual-reporter
mycobacteriophages to visualize and quantitate persistent M. tuberculosis cells. Altogether, these new tools
will enhance our understanding of persistence, thereby leading to improved TB therapies.

Public health relevance
PROJECT NARRATIVE For three decades, this proposal has developed previously unavailable genetic tools to probe Mycobacterium tuberculosis biology and has now expanded to encompass persistence, the capacity of M. tuberculosis to resist sterilization in mammals. Elucidation of M. tuberculosis persistence mechanisms is pivotal to overcome current impediments to Tuberculosis (TB) control. This submission develops new tools to study persistence in M. tuberculosis in response to first- and second-line TB drugs with the goal of providing new strategies to shorten chemotherapies for both drug-sensitive and drug-resistant TB.